MHC Genetic Typing Core

PROJECT SUMMARY - CORE 003 MHC GENETIC TYPING CORE
Macaca nemestrina serves as a critical animal model for the study and treatment of AIDS and AIDS-related
diseases. The MHC Genetic Typing Core ensures that MHC Class I alleles, lineages, and haplotypes are
determined for all animals in the SPF breeding colony, using RNA expressed allele analysis. This information is
provided to investigators to aid in animal selection and data analysis. In addition, parentage is confirmed for all
animals using a 96 single nucleotide polymorphisms (SNP) panel developed specifically for M. nemestrina during
the previous cycle of this cooperative agreement and fully implemented during the current cycle. We are initiating
a project to generate whole genome sequences from representative colony animals to provide a foundation for
identification of variations associated with specific phenotypes, both within the M. nemestrina population as well
as among different macaque species.